Regulators of Food Intake

Energy intake and dietary macronutrient composition is the most difficult part of the energy balance equation to measure. Using an in patient computerized vending machine system, food intake has been measured over 180 individuals. In individuals undergoing the study more than once the intra-class correlation coefficient is very high (r=0.9) indicating that these studies although performed in an inpatient setting are very reproducible. Eating during nighttime hours is a behavior that may predispose individuals to obesity. We had previously found that nearly 30% of volunteers ate from our vending machines during the night. These individuals consumed overall more calories and gained more weight over a 3 year follow-up period. In addition, these individuals have higher respiratory quotients measured in our respiratory chamber while on a weight maintenance diet indicating an increased drive for food intake. Despite these differences, we have not found differences in anorexigenic or orexigenic hormone levels in these individuals. Higher respiratory quotient, the ratio of carbohydrate oxidation to lipid oxidation, is known to predict weight gain. The mechanism of this increase in weight was thought to be secondary to a lower lipid oxidation in these individuals. Higher respiratory quotient measured during weight maintenance also predicted food intake during the ad-libitum vending machine study. However the component of respiratory quotient which best predicted food intake was higher carbohydrate oxidation indicating a role for carbohydrate (likely glycogen) balance in the regulation of short term food intake. To further investigate whether carbohydrate balance influences food intake, we fed individuals (in random order) a high fat versus high carbohydrate diet followed by ad libitum food intake. We did not find any difference in food consumption after either diet. However, more obese individuals tended to eat more after the high fat compared with the high carbohydrate diet and the opposite was true in leaner individuals, indicating that adiposity is associated with alteration in responses to ingested macronutrients. We have also completed a study investigating the effects of overfeeding on energy intake and physical activity. In a random cross over design we found that individuals did not down regulate energy intake after overfeeding. Moreover, increased overfeeding and weight gain were associated with an increase in sedentary behavior which was associated with greater weight gain. To develop methods to measure free living food intake, we are beginning studies which will validate chewing and swallowing monitors using our automated vending machines. We have also begun a study which will investigate stable isotopes as biomarkers for dietary patterns. Individuals (n=40) will consume diets over 3 months which vary by meat, soda and fish content and plasma, hair, and adipose tissue samples will be analyzed for changes in the stable isotopes C13 and N15. We will also investigate how these dietary patterns affect behavioral and performance testing, glucose tolerance and energy expenditure.